Immunology Training Grant

DESCRIPTION (provided by applicant): This training program is designed to provide pre- and postdoctoral candidates with the individual intellectual and technical skills required to become outstanding academic scientists in the field of Immunology. The aim is to utilize the growth of Immunology and the expansion of its faculty at Mount Sinai as a resource to create a fertile environment for the development of graduate students and postdoctoral fellows. Each trainee is exposed not only to direct laboratory research but also has the opportunity (actually required) to participate in the educational programs focused on Immunology established here at Mount Sinai. For physician scientists there will be ample opportunity to immerse themselves in translational research programs relating to cytokine biology, cancer, neurobiology, HIV related disorders, food allergy, mucosal immunity, autoimmunity and primary immune deficiency. There is formal course work, seminar series, journal clubs, a yearly retreat, and work in progress meetings (attended by the entire Immunology faculty and trainees). A single faculty member acts as a preceptor for a given fellow or graduate student supervising his/her laboratory work, orchestrating an appropriate training program (e.g. course work), and providing an environment that will help foster maturation towards an independent career in Immunology research. The program has successfully recruited outstanding trainees from a number of prestigious institutions who have been attracted to Mount Sinai because of the enormous growth in the basic sciences, excellence in research, interactive faculty, a protective and nurturing mentoring environment and a clear commitment to student and postdoctoral fellowship training.

Public health relevance
PUBLIC HEALTH RELEVANCE: This training program is designed to provide pre- and postdoctoral candidates with the individual intellectual and technical skills required to become outstanding academic scientists in the field of Immunology. The aim is to utilize the growth of Immunology and the expansion of its faculty at Mount Sinai as a resource to create a fertile environment for the development of graduate students and postdoctoral fellows.